Optimizing Induction Conditions for Immunotherapeutic CTL

DESCRIPTION (provided by applicant): The project goals are 1) to develop biocompatible nanoparticles (NP) bearing Pattern Recognition Receptor (PRR) molecules, i.e., agonists for Toll Like Receptors or C-type Lectin Receptors, 2) to determine if these NP- PRR differently affect activation of dendritic cells (DC), 3) to determine if the differently activated DC then influence the generation and functionality of T effector cells, and 4) to evaluate the alloreactive CTL and the autologous tumor associated antigen (TAA)-directed CTL in the GL261 mouse glioma model, where the tumor cell inoculum either is or is not enriched for brain tumor stem cells (BTSC). The latter goal will allow for a determination of BTSC immunosensitivity/immunoresistance. The cancer immunotherapy approach will: Use various NP-PRR (CpG DNA, imiquimod, LPS and mannosylated BSA) that will be components of a biocompatible PLGA carrier matrix already approved for clinical use to stimulate DC to variable activation states. In some experiments complex NP-PRR will also contain tumor associated antigens (mEphA2, hgp100, mTRP-2 and GARC-1) Use conventional and Flt3 ligand DC derived from immature bone marrow (BM) as precursor cells NP-PRR activated DC will then be used to stimulate alloreactive or autologous naive T cells to effector cytotoxic T lymphocytes (CTL) NP-PRR stimulated DC and subsequently stimulated CTL will be functionally and phenotypically characterized in vitro.Stimulated alloreactive CTL or TAA-directed CTL will be functionally and phenotypically characterized for their antitumor effects after their adoptive transfer into mice bearing serum-cultured GL261 or the neurosphere-cultured counterpart.

Public health relevance
PUBLIC HEALTH RELEVANCE: The work proposed here is an interdisciplinary project in translational medicine that brings together several key elements: 1. Cytotoxic T Lymphocytes (CTL)-effector cells for immunotherapy 2. Dendritic Cells (DC)-antigen presenting cells (APC) used to induce CTL effectors in vitro 3. Nanoparticles (NP) and their payload-activation stimuli and antigens delivered to DC 4. Brain Tumor Stem Cells (BTSC)-therapy-resistant tumor cells that should be included as targets of the effector cells The goal of this project is to modulate dendritic cell activation with pathogen associated signaling molecules contained with nanoparticles. These nanoparticles will be used to stimulate dendritic cells to various activation states. The dendritic cells will then be used to stimulate naive T cells into effector cells. The generated CTL will be functionally and phenotypically characterized in vitro and in vivo using mouse glioma cell targets or those enriched for brain tumor stem cells in culture. PROJECT NARRATIVE The work proposed here is an interdisciplinary project in translational medicine that brings together several key elements: 1. Cytotoxic T Lymphocytes (CTL)-effector cells for immunotherapy 2. Dendritic Cells (DC)-antigen presenting cells (APC) used to induce CTL effectors in vitro 3. Nanoparticles (NP) and their payload-activation stimuli and antigens delivered to DC 4. Brain Tumor Stem Cells (BTSC)-therapy-resistant tumor cells that should be included as targets of the effector cells The goal of this project is to modulate dendritic cell activation with pathogen associated signaling molecules contained with nanoparticles. These nanoparticles will be used to stimulate dendritic cells to various activation states. The dendritic cells will then be used to stimulate naïve T cells into effector cells. The generated CTL will be functionally and phenotypically characterized in vitro and in vivo using mouse glioma cell targets or those enriched for brain tumor stem cells in culture. __SpecificAimsTextDelimiter__ SPECIFIC AIMS This is a Multiple PI application from investigators, Drs. Carol Kruse and Boris Minev, who bring shared and complementary expertise to this application. The research pursuits described are a natural outgrowth of their interests in passive (cellular) and active (vaccine) immunotherapy approaches to cancer therapy. The Kruse lab has extensive experience with in vitro generation of alloreactive cytotoxic T lymphocytes (alloCTL) and their therapeutic use for gliomas in in vitro and murine models and in clinical studies. The Minev lab has expertise in the dendritic cell vaccine field and has successfully made nanoparticles for delivery of antigenic peptides (see Appendix 2). The work proposed here is an interdisciplinary project in translational medicine that brings together several key elements: 1. Cytotoxic T Lymphocytes (CTL)-effector cells for immunotherapy 2. Dendritic Cells (DC)-antigen presenting cells (APC) used to induce CTL effectors in vitro 3. Nanoparticles (NP) and their payload-activation stimuli and antigens delivered to DC 4. Brain Tumor Stem Cells (BTSC)-therapy-resistant tumor cells that should be included as targets of the effector cells Given the highly interdisciplinary nature of this work, the investigators have also enlisted the assistance of other experts: Dr. Sadik Esener with experience in nanomedicine, Dr. Martin Jadus with expertise in tumor associated antigen (TAA) characterization in gliomas for generation of whole tumor vaccines (see Appendix 1), Dr. Patric Schiltz an immunologist with a background in the culture and flow cytometric characterization of T cells and DC, and Dr. James McCormack a T cell immunologist with regulatory experience in readying biologics for clinical application (see letters). For immunotherapy of cancer, the induction of anti-tumor cytotoxic responses has shown great promise experimentally, but limited clinical success. The concept of immunotherapy through stimulation of tumor- specific CTL is well established, but the ability to simply and reliably induce appropriate CTL responses- whether ex vivo or in vivo-remains an elusive goal. One focus in this proposal will be to optimize conditions for the induction of immunotherapeutic CTL-specifically, ex vivo generation of CTL. The CTL will be generated as effectors for glioma cells, where we will also include a focus on highly radio- and chemo-therapy resistant BTSC as targets. We will additionally integrate the use of NP for delivery of stimuli by DC. NP have been shown to deliver peptide antigens to DC that in turn can activate CTL. In light of the general observation that the nature and function of responder T cells is influenced by a) the identity of APC involved in their stimulation, and b) the activation status of those APC, WE HYPOTHESIZE that the efficacy of ex vivo generated immunotherapeutic CTL can be optimized by screening different DC activation conditions using NP-PRR. We propose to evaluate the influence of different NP-PRR agonists on DC activation status and on the downstream activation of CTL. Effectors will be subjected to in vitro analysis and in vivo testing in a murine glioma model. The study design will guide and support two Specific Aims: 1) Optimize in vitro induction of alloreactive CTL, and 2) Optimize in vitro induction of autologous antigen-specific CTL. SPECIFIC AIM 1: OPTIMIZE INDUCTION OF ALLOREACTIVE CTL In the first aim we will develop and then use NP bearing Pattern Recognition Receptor (PRR) agonists to activate conventional and Flt3 ligand DC cultured from immature BM precursor cells. DC will be evaluated to determine how stimulation with NP-PRR affects activation status and TLR/CLR expression. The NP-PRR stimulated DC will then be used as stimulator cells for the generation of alloCTL. The ultimate goal is to develop a means of directing alloCTL to develop distinct characteristics and effector function from those generated following conventional one-way MLR. The antitumor function of different alloCTL preparations will be evaluated in vitro and in a mouse model of glioma. A. Develop production and characterization techniques for NP-PRR 1. Biocompatible PLGA NP containing different PRR agonists (CpG DNA, imiquimod, LPS and mannosylated BSA) will be manufactured and characterized for particle size, surface potential and morphology. 2. Potency assays will be developed and used for assessing the various active agents incorporated into the NP-PRR. B. Evaluate DC activation status and functionality following activation with NP-PRR. PRR to be tested include: " CpG DNA TLR 9 agonist " Imiquimod TLR 7 agonist " LPS TLR 4 agonist " Mannosylated BSA CLR agonist (C-type lectin receptor) The DC characterization will include: 1. Phenotypic analysis will evaluate expression of MHC class I and II, costimulatory markers, and TLR/CLR's. 2. Functional response to stimulation will be evaluated by measuring Th1 and Th2 cytokine secretion. C. In vitro phenotypic and functional characterization of alloCTL stimulated with DC activated with NP-PRR 1. Phenotypic analysis will evaluate expression of costimulatory molecules 2. Th1, 2 and 3 cytokine secretion will be evaluated following alloCTL restimulation with irradiated allostimulator cells. 3. Cytotoxic activity against relevant target cells: GL261 glioma cells grown in a) serum-containing medium, or b) neurosphere culture medium--targets enriched for BTSC. Cytotoxic activity will be discerned by scattergrams of 7AAD stained target cells that distinguish lysis from apoptosis. D. In vivo testing of intratumorally-administered alloCTL stimulated with DC activated with NP-PRR Using the mouse GL261 tumor model or the neurosphere-cultured BTSC counterpart: 1. Histological assessments will be made to determine alloCTL mobility and tumor cell injury 24 hr after intratumoral alloCTL delivery. 2. Efficacy of alloCTL delivered intratumorally will be determined using tumor volumetric and survival studies. SPECIFIC AIM 2: OPTIMIZE INDUCTION OF AUTOLOGOUS ANTIGEN-SPECIFIC CTL In the second aim we will test the induction of autologous antigen-specific CTL responses. DC will be stimulated with NP-PRR that are also complexed with tumor associated antigen(s) (TAA). Four TAA that are expressed in the GL261 mouse glioma model (mEphA2, hgp100, mTRP-2 and GARC-1) [26; 113] will be individually copackaged with the NP-PRR (NP-PRR-TAA). NP-PRR-TAA stimulated DC will be used to generate TAA-specific CTL. Both will be characterized in vitro using autologous stimulation of naïve C57B/6 splenocytes. Then, the anti-tumor function of TAA-CTL delivered systemically or intratumorally will be evaluated in vivo using the mouse GL261 glioma model. The goal is to generate TAA-CTL that are functionally superior to peptide antigen specific CTL generated by standard one-way mixed tumor lymphocyte reaction (MLTR). A. Production and characterization of NP-PRR-TAA Biocompatible PLGA NP will be produced to contain different PRR agonists and a TAA. Four TLR/CLR agonists (CpG DNA, imiquimod, LPS, mannosylated BSA) will be combined with individual TAAs (mEphA2, mgp100, mTRP-2, and GARC-1). The NP-PRR-TAA will be characterized for particle size and surface potential. Potency assays will assess the various active agents and amount of peptide incorporated. B. In vitro characterization of DC and TAA-specific CTL generated with them 1. Phenotypic and cytokine secretion analyses of DC following activation with NP-PRR-TAA 2. Phenotypic and functional (i.e., cytokine secretion and cytotoxicity) characterization of TAA- CTL. GL261 brain tumor cells and its neurosphere-cultured BTSC will be the targets. C. In vivo studies involving either systemic or intratumoral adoptive transfer of TAA-specific CTL as immunotherapy in C57BL/6 mice bearing serum-cultured GL261 glioma cells or their neurosphere- cultured BTSC enriched counterpart. Assessments will be by: 1. Histopathologic study 2. Tumor volumetric studies using computerized histomorphometry 3. Survival assessments